Enhancing Neuroscience Research through Inclusiveness, Culture and Health (ENRICH)

PROJECT SUMMARY
In the 21st century it has become clear that many of the major problems facing humanity will need to be addressed
by biologists carrying out biomedical research. In order for the US biomedical research community to succeed in
combating the major challenges facing our world, scientists will have to operate with high efficiency and develop
solutions to many different unique problems. A broad number of studies have now concluded that teams and
organizations that are diverse and inclusive are more successful at these endeavors. Moreover, if public funding is to
be used to support biomedical research, in order for it to be equitable, it should allow access to students from all
backgrounds and represent the diversity in the US population. Success as a scientist requires more than just skill at
a lab bench and there are special barriers facing students from underrepresented groups. Therefore, our
comprehensive approach will implement (1) enhanced educational and research outreach to minority-serving
institutions, (2) recruitment activities to help students transition to our university, (3) advanced start activities to
help students transition readily to the next stage in their training, (4) coursework and activities that are relevant
to their underserved communities and themselves, (5) faculty- AND peer-mentoring support, coupled with
culturally-aware mentor training, (6) UCI research and collaboration visit opportunities for their prior
undergraduate mentors who likely inspired them to enter graduate school, (7) funding to support an annual
”reconnection” visit to their alumni institution and community, (8) funding for them to attend conferences, such
as SACNAS, ABRCMS and SfN, and (9) training in oral and written communication and leadership skills. Taken
together, these opportunities will prepare students for careers inside and outside academia and will advance the NIH
goals of enhancing biomedical research in the context of health and human services as a whole.

Public health relevance
PROJECT NARRATIVE Many studies now firmly support the idea that diversity makes teams and organizations stronger. Moreover, in order for taxpayer money to be equitably utilized there should be equal opportunities for individuals from every type of background to engage in research supported by taxpayer money and for their communities to benefit from such research. Here, we propose to provide educational and personal development activities to encourage individuals from diverse backgrounds to enter academia. We propose to create a new form of mentoring ecosystem to support their inclusiveness and promote their involvement and success within scientific and academic communities. The goal of this program is quite simply to train graduate students for successful careers to diversify the biomedical research workforce and to be active future leaders with skills that will enable them to further promote diversity, equity, inclusion and accessibility.